Human Subject Core

Human Subjects Core (HSC)
Center for Bio-behavioral Mechanisms of Eating Behavior
SUMMARY/ABSTRACT
We propose to establish a Center of Biomedical Research Excellence (COBRE) at the Sanford Center for Bio-
behavioral Research (SCBR; Fargo, ND) in collaboration with the North Dakota State University (NDSU)
Departments of Psychology and Pharmaceutical Sciences and the University of North Dakota School of Medicine
(UNDSOM). This center will focus on conducting cutting-edge, innovative research on the mechanisms related
to the onset and maintenance of eating disorders and eating behaviors.
Objectives
1. To enhance Project Directors’ education about regulatory aspects of human subjects research.
2. To provide human subjects research support to optimize and streamline research project activities for Project
Directors.
3. To facilitate consultation and collaboration by increasing awareness of other research centers conducting
human subjects research in the area of eating disorders and eating behavior.
Methods
The HSC will provide educational experiences for Project Directors and provide hands-on training and
experience in navigating regulatory issues in human subjects research. The HSC will therefore provide both
didactic education and mentoring in terms of human subjects regulatory activities. Additionally, the HSC wishes
to broaden Project Directors’ awareness of other research centers conducting human subjects research in eating
disorders and eating behavior to facilitate greater consultation and collaboration for Project Directors.